Engineering Extracellular Vesicles of Human Brain Organoids for Stroke Therapy

Project Summary/Abstract
Currently, about 4 million Americans are living with the effects of stroke, but there is no
effective treatment to improve functional recovery. The stroke-damaged site is especially
cytotoxic to neurons because of the high susceptibility to reactive oxygen species and pro-
inflammatory enzymes. It was recently realized that cellular secretome may be the major
contributor during stem cell therapy. Extracellular vesicles (EVs), the membrane-bound
microvesicles, represent an active component of the cell secretome. And a major contributor to
the activity of EVs is the microRNA cargo. Since 2013, derivation of brain organoids from human
induced pluripotent stem cells (iPSCs) has emerged as a promising approach for mimicking three-
dimensional human brain tissue. However, current knowledge on the therapeutic benefits of EVs
secreted by iPSC-derived brain organoids is limited.
The objectives of this research are to engineer EVs of brain organoids derived from human
iPSCs (iNPCo) and investigate the impacts of iNPCo-secreted EVs on the survival, biosynthesis
of trophic factors and extracellular matrices, and functional neural differentiation in vitro and in
vivo. The central hypothesis is that iNPCo, unlike naïve iPSCs and monolayer neural progenitors,
secrete EVs carrying brain-specific microRNA cargo that can target ischemic brain tissue both by
providing neuroprotection from injury and by promoting recovery after injury; in particular, heparin-
hyaluronic acid hydrogel encapsulation will allow for the sustained delivery of iNPCo-EVs in the
ischemic environment, promoting their therapeutic effects. Based on these hypotheses, we
propose three aims: (1) Aim 1 will test the hypothesis that iNPCo-EVs express exosomal markers
and promote cell survival under oxidative stress in vitro; (2) Aim 2 will test the hypothesis that the
microRNAs in iNPCo-EVs regulate the Wnt pathway and the secretion of trophic factors and
extracellular matrices to stimulate neurogenesis in vitro; and (3) Aim 3 will test the hypothesis that
iNPCo-EVs promote in situ neural differentiation and tissue regeneration in an ischemic stroke
model. To date, no EV study has been performed for brain organoids derived from human iPSCs yet.
The novelty of our study in contrast to previous EV study is the use of three-dimensional brain
region-specific organoid system and the tunable heparin-hyaluronic acid hydrogel encapsulation
for therapeutic EV delivery. This project will advance our understanding of the effects of paracrine
signaling on neural regeneration and establish a transformative approach to modulate
extracellular microenvironment to attenuate ischemic-associated neuropathology toward the goal
of promoting neural regeneration through novel therapeutics.

Public health relevance
Project Narrative: The proposed work will engineer and characterize extracellular vesicles secreted by 3-D brain region-specific organoids derived from human induced pluripotent stem cells and investigate the impacts of paracrine signaling on neural function in vitro and in vivo for ischemic stroke therapy.